Enhancing the Safety, Efficiency, and Research Capacity of the University of Pittsburgh Regional Biocontainment Laboratory to Study Virus Families of Greatest Pandemic Concern

Abstract.
In 2008, the University of Pittsburgh opened a Regional Biocontainment Laboratory (RBL).
Research at the RBL has grown significantly since then, with investigators working on several
highly infectious microbial agents requiring BSL2 and ABSL2 facilities. Current RBL research
projects cover multiple viruses in 5 of the 7 RNA virus families of pandemic concern as defined
by NIH, including, Bunyavirales, Coronaviridae, Flaviviridae, Paramyxoviridae, and Togaviridae.
The RBL is an invaluable resource for the University of Pittsburgh, western Pennsylvania, and
institutions in the US, Europe and South America. Indeed, the RBL received the SARS-CoV-2
virus in mid-February, 2020, and received almost $5M in March 2020 from the international
Coalition for Epidemic Preparedness Innovations to pursue vaccine development for COVID-19.
The continued success of the RBL is essential for the US to conduct the necessary research to
be prepared for the rapid development and testing of vaccines and therapeutics in response to
future pandemics similar to the recent SARS-CoV-2.
Over the last 14 years, the infrastructure and facilities in the RBL have begun to degrade, with
some reaching the end of their usefulness. The focus of this application is to modernize the RBL
through both upgrades and renovations that are designed to allow for continuing cutting-edge
research on infectious agents of pandemic concern for many years to come. An effective and
efficient RBL is a vital tool for pandemic preparedness.
To accomplish our goals, 3 areas of RBL functionality and efficiency will be addressed. First, we
will enhance RBL safety and longevity. Repairs or replacements will be made to the bio-
containment flooring, the supply air system, the exhaust system, variable frequency drives, chiller
controls, steam water heaters, diesel engine generator fuel system controls, fire alarm system,
building automation system, walk-in cooler, and biometric security. Second, the efficiency of RBL
operations will be enhanced by replacement of existing system lighting with energy-efficient LED
lights and removal of a gas plasma sterilizer to generate much needed space. Third, the research
capacity of the RBL will be enhanced by increasing rodent housing capacity and purchasing
additional caging for non-human primates, rabbits, and ferrets.
The ultimate goal of this proposal is to ensure the RBL remains functional, efficient, and ready for
rapid response to future emerging pandemics.